The Research Capacity Core of SDSU HealthLINK Center for Transdisciplinary Health Disparities Research

RESEARCH CAPACITY CORE – Project Summary
The SDSU HealthLINK Center for Transdisciplinary Health Disparities Research (Center) was established in
2018 to augment individual investigator and partner capacity, as well as institutional capacity, for minority
health and health disparities (MHHD) research. Despite many improvements over the first 5 years of the SDSU
HealthLINK Center, SDSU, SDSU Imperial Valley (SDSUIV), and community partners continue to have
significant gaps in core research infrastructure critical for fostering innovative transdisciplinary MHHD research.
The objective of the Research Capacity Core (RCC) is to continue to maximize the quality and productivity of
MHHD research conducted at SDSU, SDSUIV, and community partners. We propose the following two specific
aims that align with the goals of the RCMI specialized centers: 1) expand and sustain needed infrastructure
and institutional capacity to support innovative transdisciplinary research at SDSU and SDSUIV using the
latest technologies and theories in MHHD research; and 2) collaborate with the Center’s other Cores and
Projects to maximize quality and productivity of MHHD research at SDSU and SDSUIV. To accomplish Aim 1,
RCC will develop a Sensor Demonstration Lab; develop training and consultation in data science; develop
protocols and training programs to facilitate and support research in implementation science; develop and
implement a research ethics training program; and expand the range of common data elements to include
demographic and health measures specifically tailored towards youth. To accomplish Aim 2, RCC will
collaborate with the Administrative Core (AC) to provide career enhancement seminars, support Center
evaluation data collection, and share resources through the Health Science Research Portal. RCC will work
with IDC to increase research skills of PP leaders through collaboration on IDC’s Information Sessions, Grant
Writing Workshops, and Research Management Training Program. Through collaboration with the Community
Engagement Core (CEC), the RCC will provide guidance on research ethics, best practices for communicating
with research participants, and community-engaged data/resource sharing. Through the provision of research
resources and services, the RCC will also assist the new Recruitment Core (RC) faculty member and enhance
the quality, productivity, and completion of RPs and PPs. Finally, the RCC will continue to expand its cost
recovery service offerings. The Center RCC will continue to develop innovative and rigorous research services
and resources of great need for SDSU, SDSUIV, and community partners. These resources and services, plus
the support provided to RP, PP, the hired RC faculty member, and cost recovery service investigators will
make a significant impact in improving minority health and reducing health disparities.